Trispecific CAR-T cells targeting CD19, CD20 and CD22 to treat B-cell malignancies

Project summary
CD19 targeted chimeric antigen receptor T cells (CAR-Ts) have revolutionized cellular immunotherapy in
refractory B-cell malignancies such as B-cell Non-Hodgkin’s lymphoma (B-NHL) and B-cell acute lymphoblastic
leukemia (B-ALL). Despite high rates of complete remissions, relapses, 50% of which within the first year,
remain a critical challenge highlighting the need for novel CAR-T cell products. Two patterns of relapse are
observed: (i) Antigen-negative relapses, caused by target antigen loss and (ii) antigen-positive relapses, which
are mediated by lack of persistence or loss of function of the CAR-Ts. Commercial CD19 CAR-Ts employ
either a CD28 or a 4-1BB costimulatory domain however, a novel OX-40 domain has been shown to promote
persistence, cytotoxicity and decrease exhaustion. Finally, increasing evidence suggests that stem-like
memory T cell phenotype in the CAR-T product is associated with more durable responses. Schneider et. al
developed a Trispecific CD19, CD20, CD22-targeting CAR-Ts with an OX-40 costimulatory domain and
showed significant activity in preclinical lymphoma models compared to CD19 CAR-Ts. We validated these
findings with in-house manufactured Trispecific CAR-Ts and confirmed their specificity, cytotoxicity, and
immunophenotypic fitness in preclinical B-cell lymphoma models. Our proposal seeks to address the limitations
of commercial CD19 CAR-Ts through a first-in-human in-house manufactured Trispecific CAR-Ts with an OX-
40 costimulatory domain for relapsed, refractory B-cell malignancies. These trispecific CAR-Ts are
manufactured in the Ohio State University Cell therapy laboratory using the CliniMACS Prodigy device over a
6-day manufacturing process which allows for infusion of stem-like memory CAR-Ts. We hypothesize that
trispecific CARTs will (i) reduce the risk of relapse mediated by antigen negative clonal escape; (ii) enhance
persistence of CAR-Ts which will translate into deeper and more durable clinical responses. To address this,
we propose two Aims. In Aim 1, we aim to conduct a first-in-human phase I trial with in-house manufactured
trispecific CAR-Ts in patients with relapsed/refractory B-NHL, B-ALL, B-prolymphocytic leukemia, and chronic
lymphocytic leukemia. Primary endpoints are feasibility, safety of trispecific CAR-Ts along with establishing a
recommended phase II dose. Secondary endpoints are efficacy and duration of response. In Aim 2, we aim to
identify key mechanisms of efficacy and resistance to trispecific CAR-Ts. Specifically, we plan to assess: (i)
persistence of CAR-Ts and its correlation with complete remission rates, duration of response as well as
incidence and severity of adverse events; (ii) immunophenotypic and transcriptional features of impaired
function of CAR-Ts and other mononuclear cells using state of the art high-dimensional spectral flow cytometry
and CITE-sequencing.
At completion of this project, our work will have established feasibility of in-house manufacturing of trispecific
CAR-Ts and provided insights into mechanisms of relapse and efficacy.

Public health relevance
Project narrative The chimeric antigen receptor T cells (CAR-Ts) is a novel therapeutic strategy that uses the patient’s own T cells to kill the tumor cells. This approach has changed the treatment landscape of B-cell malignancies however a significant percentage of patients with these diseases unfortunately relapse after CARTs infusion with limited effective treatment options available to them. Here, we propose the first in human clinical trial with in-house manufactured CAR-Ts targeting three proteins at the same time in patients with B-cell tumors with the goal of improving over the results of single antigen CAR-Ts.